Promoting weight-related health in the next generation of adolescents and young adults:A comprehensive program of research

ABSTRACT
Promoting weight-related health is vital to cardiovascular health and a public health priority. The Project
EAT (Eating and Activity over Time) research has informed a paradigm shift regarding how to address weight-
related health. Specifically, findings have shown the need to address the full spectrum of weight-related health,
including weight status, dietary intake, physical activity, body image, disordered eating (e.g., binge eating,
unhealthy weight control practices), and eating disorders, in addition to social determinants of these outcomes.
The socio-environmental contexts of adolescents and young adults today (i.e., those who make up
Generation Z born between 1997-2012) have dramatically changed since Project EAT began following
adolescent Millennials (i.e., those born between 1981-1996) in 1998. For example, there have been vast
changes in technology and young people are being exposed to a proliferation of image-based social media
(e.g., TikTok) with mixed messages about weight-related health (e.g., new weight loss medications, body
positivity). If we are to effectively promote weight-related health and health equity across ethnicity/race and
socio-economic status in the next generation of young people, it is crucial to understand the most salient
issues facing today’s adolescents and young adults. The ultimate goal of this R35 is to promote the broad
spectrum of weight-related health in the next generation of adolescents and young adults.
To achieve this goal, the R35 will integrate research, community partnerships, and training. For the first
time, Project EAT will collect data on a national sample of 2000 Gen Z adolescents and young adults.
Additionally, we will leverage the existing Project EAT Millennial-generation cohorts by collecting data from both
cohort members and their Gen Z adolescent and young adult children (expected n=1000 parent-child dyads),
for an intergenerational study across two generations of young people. We will also conduct qualitative data
collection for a deep understanding of the weight-related issues facing Gen Z young people; rapid response
surveys to assess the impact of socio-environmental influences in real time; and innovative substudies for in-
depth explorations of timely topics. The result will be the most comprehensive dataset to date on weight-
related health among diverse adolescents, young adults, and their parents. To ensure that our data are used to
make a positive difference, we will work in partnership with two Community Advisory Boards; one comprised of
diverse adolescents and young adults and the other comprised of professionals (e.g., health care providers).
We will also integrate training throughout the research program to ensure that future scientists are prepared to
address weight-related health in young people, particularly those from marginalized backgrounds.
This R35 aligns with the NHLBI Strategic Vision. It will support a highly dedicated and productive
researcher, along with a strong team, to carry out a timely, impactful, and innovative program of research and
training to significantly advance science, enhance weight-related health, and work toward greater health equity.

Public health relevance
NARRATIVE This R35 will comprehensively address how to prevent and reduce the broad spectrum of weight-related health problems, including obesity, poor dietary intake, inadequate physical activity, body dissatisfaction, disordered eating (e.g., binge eating, unhealthy weight control practices), and eating disorders, in Gen Z adolescents and young adults. Data from two longstanding population-based studies will be combined with new data collection on national and intergenerational samples, which will result in a rich and comprehensive data source on the weight-related issues facing Gen Z adolescents and young adults. Throughout the program of research, we will engage community partners and integrate training of future scientists, with the ultimate goal of promoting weight-related health in the next generation of adolescents and young adults.